GENETIC EPIDEMIOLOGY FOR DYSLIPIDEMIA AND CORONARY ARTERY DISEASE

This system is used to prepare data sets for analysis on another cluster of workstations where genetic analysis of dyslipidemia is done.